Admin supplement to ESTEEMED Scholars Program in Bioengineering at the University of Colorado Denver

This NIH Diversity, Equity, Inclusion, and Accessibility (DEIA) supplement seeks to enhance
the parent grant by focusing on mentor training and development, ensuring that the next
generation of bioengineering scholars are equipped with the skills necessary for postgraduate
success in bioengineering, biomedical sciences, and medicine. The overall objective of this
supplement is to enhance the mentorship capacity within our program, ensuring that faculty
and peer mentors are equipped to support our students effectively. This enhancement will
complement the parent grant's aims by providing a structured mentoring framework that
promotes inclusion, supports science identity, and fosters academic and professional
development. To achieve the overall objective, we will pursue the following specific aims: (1)
Facilitator training for the Entering Mentoring curriculum and workshop, (2) Entering Mentoring
implementation and assessment. The workshop will be implemented across the College of
Engineering, Design and Computing at CU Denver and will addresses the following themes:
aligning expectations, addressing equity and inclusion, articulating your mentoring philosophy
and plan, assessing understanding, cultivating ethical behavior, enhancing work-life
integration, fostering independence, maintaining effective communication, and promoting
professional development. Mixed methods (quantitative and qualitative) will be used to collect
data and analyze findings, along with validated quantitative surveys in educational
programmatic intervention research. Results will be disseminated across the College and
University, at regional and national engineering education conferences, and in peer reviewed
journals. We anticipate successful completion of these aims will lead to increased retention
and success rates of students from diverse backgrounds in bioengineering, biomedical
sciences, and medicine. Furthermore, by creating a replicable model of effective mentorship
training and implementation, this supplement has the potential to positively impact not only the
University of Colorado Denver but also other institutions wishing to enhance their mentorship
capabilities.

Public health relevance
The proposed administrative supplement to recognize excellence in Diversity, Equity, Inclusion, and Accessibility (DEIA) mentorship seeks to enhance the mentorship capacity within the parent award (R25, Enhancing Science, Technology, EnginEering, and Math Educational Diversity) ensuring that faculty and peer mentors are equipped to support our students effectively. The proposed research is relevant to the part of NIH's mission that pertains to developing the human resources that will ensure the Nation's capability to prevent disease.